Investigating Mechanisms of Intra- and Inter-individual Pain Variability in Patients with Comorbid Chronic Pain and Depression

PROJECT SUMMARY/ ABSTRACT
Chronic low back pain (cLBP) is the most common musculoskeletal pain condition associated with substantial
inter-individual variability. Further, major depressive disorder (MDD) is comorbid in up to 46% of individuals with
cLBP, which is related to worse pain and depression severity, disability, and quality of life, and poorer response
to existing treatments compared to cLBP alone. MDD is itself a heterogenous condition, and thus any association
with cLBP also likely varies between individuals. While the biopsychosocial model has been helpful for identifying
biological, psychological, and social processes associated with cLBP, as well as helping to explain the overlap
between cLBP and MDD, a major challenge in optimizing the treatment is identifying which factors, and in which
combination, are most related to an individual’s unique pain experience. In response to the Notice of Funding
Opportunity for Understanding Individual Differences in Human Pain Conditions, the proposed research will
generate individualized prediction models of momentary pain intensity among 150 adults with cLBP+MDD (Aim
1). This will be accomplished by a combination of ecological momentary assessments (EMA) and whole-health
metrics obtained from wearables, all processed with a robust machine learning (ML) pipeline previously validated
in our laboratory. We hypothesize that personalized prediction models of pain variability using ML algorithms will
be feasible in at least 80% of participants, achieving ~80% prediction accuracy. After obtaining individualized
models on the study sample, we well then apply data-driven clustering algorithms to identify subgroups of
participants that share top features of individual pain variability (Aim 2a) and relate these clusters to underlying
biological mechanisms implicated in cLBP+MDD (emotion bias and reward processing with concurrent EEG and
laboratory measures of central sensitization) (Aim 2b). We hypothesize that unique phenotypes will emerge
characterized by shared features of individual pain variability and that empirically-derived phenotypes will be
related to distinct biological mechanisms. This application holds promise to make a major contribution to the
scientific knowledge of both intra- and inter-individual pain variability in persons with cLBP+MDD. This approach
represents a shift in current research practices, which has largely focused on analysis at the group level, by
taking a data-driven approach to elucidate individual differences in cLBP+MDD. Further, our clustering approach
in Aim 2 is highly novel, which groups individuals based on top features of individual pain variability, enabling a
high precision method of identifying homogenous subgroups and examining putative underlying mechanisms of
cLBP+MDD subtypes.

Public health relevance
PROJECT NARRATIVE Progress towards elucidating intra- and inter-individual differences in chronic pain has been modest. We propose to combine high frequency biopsychosocial data collected over a 30-day period with machine learning to obtain individualized models of pain variability in adults with comorbid chronic low back pain and depression.